Genetic and Molecular Studies of Neurogenesis

DESCRIPTION (provided by applicant): We are investigating how the central nervous system (CNS) is assembled during embryonic development. This is has several potential human health benefits relevant to the NIH mission. First, the treatment of many neurological disorders would benefit from a method for generating specific types of neurons from the patient's own induced pluripotent stem (IPS) cells. Second, many psychiatric disorders arise in part from developmental defects. Generating therapeutic tools to treat these types of disorders will require a detailed understanding of how each neuronal subtype is normally formed. We have been investigating this question in the model organism Drosophila, which has been profoundly important for discovering mechanisms of neurogenesis relevant in mammals. Much is currently known about how neural progenitors acquire their spatial identity (e.g. forebrain vs. hindbrain) but we still know very little about how they sequentially produce different cell types. We previously identified a series of transcription factors that specify temporal identity within the Drosophila nervous system. Here we focus on three related questions in embryonic progenitors (Aims 1-3) and conclude with the first analysis of temporal identity in a newly discovered Drosophila post- embryonic neural progenitor that shares features with the primate outer ventricular zone progenitor (Aim 4). In Aim 1, we will determine whether the Hunchback transcription factor acts transiently in progenitors or continuously in post-mitotic neurons to specify first-born temporal identity. Because the mammalian Hunchback ortholog Ikaros has a similar role in specifying early-born retinal ganglion cell fates, this aim has the potential to hep design therapeutic treatments to replace a cell type essential for human vision. In Aim 2, we follow up on results from the previous funding period showing that neural progenitors lose competence over time to form early-born neuron subtypes in response to a pulse of Hunchback expression. We will determine the mechanism of progressive loss of competence in these progenitors, aided by the identification of a nuclear protein whose expression mimics the competence window, and whose prolonged expression can extend the competence window. In Aim 3, we initiate work on a new Type II neural stem cell that we and others recently discovered. Each brain lobe contains 8 type II neuroblasts that divide asymmetrically to produce a series of intermediate neural progenitors (INPs) that each also divide asymmetrically to make a sequence of 10-12 neurons. We will characterize the relationship between neuroblast or INP birthorder and the production of distinct neural subtypes. We have recently identified transcription factors expressed in sequentially in INPs, and we will determine if they specify temporal identity in these sublineages.

Public health relevance
The proposed project is relevant to public health because understanding how spatial and temporal cues are integrated by single progenitors to generate unique neuronal subtypes will help guide stem cell therapy for replacing neurons lost to traumatic brain injury (TBI), stroke, disease, or age-related degeneration. Thus, the proposed research is relevant to NIH's mission to reduce the burden to society arising from prevalent environmental and genetic brain disorders.